AUTOMATED METHOD FOR DIGITAL IMAGE QUANTITATION

The purpose of this study is to determine the best approaches for evaluation of the accuracy and reliability of the developed algorithms as compared to trained observers. This is a DSL-only protocol.